Manipulating the Reward Circuit with TMS

PROJECT SUMMARY
Abnormalities of the reward circuit have been identified in numerous psychiatric disorders
including major depressive disorder, substance abuse, obsessive-compulsive disorder, and
schizophrenia. Reward circuit dysfunction is associated with anhedonia – a subjective loss in
reactivity to pleasurable stimuli. Normalization of the reward circuit thus holds promise in the
treatment of anhedonia and associated disorders. This end requires measures that reliably track
anhedonia, and interventions that modulate anhedonia. We have done extensive work identifying
a reliable event-related potential (ERP) marker of reward sensitivity referred to as the reward
positivity (RewP). The RewP relates to behavioral and self-report measures of reward sensitivity,
structural and functional MRI measures of the reward circuit, risk for depression, and recovery
from depression. In preliminary data, we have found that a single session of intermittent theta-
burst transcranial magnetic stimulation (iTBS) targeted at the reward circuit increases the RewP
in healthy, young adults relative to iTBS delivered to a control site. If reward circuit targeted iTBS
can improve the RewP, this holds promise as an intervention that could modulate anhedonia.
However, this end requires better understanding of the mechanisms by which iTBS alters the
reward circuit, the RewP, and anhedonia.
The present proposal aims to meet this challenge. Sixty individuals with elevated anhedonia will
be recruited to receive reward circuit targeted iTBS for 5 days over 1 week, as well as iTBS to a
control site for 5 days over 1 week, each followed by a week of washout in a counter-balanced,
cross-over design. Reward sensitivity will be tracked by the RewP measured at the end of each
week along with self-reported anhedonia. The reward circuit will be examined at baseline, and at
the end of each iTBS week using blood-oxygenation level dependent (BOLD) connectivity and
reward-related activations. We hypothesize that reward circuit targeted iTBS will have both local
(cortical target) and downstream (sub-cortical) effects on BOLD activation, as well as effects on
connectivity within the reward circuit. We hypothesize that these effects on the reward circuit will
also be borne out in changes in the RewP and self-reported anhedonia. Collectively, these data
will test the hypothesis that reward circuit targeted iTBS impacts the reward circuit, reward
sensitivity, and anhedonia, paving the way towards interventions for the treatment of anhedonia.

Public health relevance
PROJECT NARRATIVE Dysfunctions of the reward circuit lead to debilitating deficits in the ability to feel pleasure, learning, and motivation. This proposal aims to use brain stimulation to focally manipulate the reward circuit and improve reward sensitivity and anhedonia. The results could potentially be harnessed to provide treatments for disorders involving the reward circuit.